Dissecting Mechanisms of Granuloma Macrophage Polarization and Granuloma Formation in Chronic Salmonella Infection

Project summary
Intracellular bacteria, most notably, Salmonella enterica and Mycobacterium tuberculosis, infect hundreds of
millions of people and cause millions of deaths annually. These pathogens can establish chronic infections to
survive long-term within host tissues. In chronic stage, many infected individuals are asymptomatic, but they can
progress to develop active disease. Currently there is a paucity of effective strategies to monitor and modulate
disease progression, reactivation risks, and therapy responsiveness for chronic bacterial infections. A key
pathological feature common to many intracellular bacterial infections is granuloma, a complex and dynamic
tissue microstructure comprised of immune cells, particularly macrophages, and pathogens. Granuloma
formation is thought to be an important immune response to control infection, but it also serves as a crucial
mechanism for pathogen persistence. Our long-term goal is to identify common pathways involved in granuloma
formation that would lead to fundamental advances in diagnostic and therapeutic modalities for chronic bacterial
infections. In the current proposal, we will take multipronged approaches to dissect mechanisms of host-
pathogen interactions underpinning granuloma formation and control of chronic Salmonella infection. In Aim 1,
we will define the mechanisms by which a critical host factor regulates granuloma formation and bacterial
persistence. The objective of Aim 2 is to identify the key pathways of granuloma formation manipulated by a
novel Salmonella virulence factor. In Aim 3, we propose to construct an innovative reporter system consisting of
genetically engineered mice and genetically engineered Salmonella to characterize development and
maintenance of granuloma macrophages.
The proposed research is a component of a mentored career development plan for the candidate to acquire a
unique interdisciplinary skillset to achieve an independent academic research career studying host-pathogen
interactions in the pathogenesis of bacterial infections. The candidate is currently an Instructor in the Division of
Pediatric Infectious Diseases, Department of Pediatrics, at Stanford University. The proposed research draws
upon the candidate’s experience in cellular immunology, bacterial pathogenesis, and clinical infectious diseases.
Together with planned didactics and technical training, the experiments outlined will provide the candidate a
framework to acquire new domains of expertise including molecular microbiology and bacterial genetics, cutting-
edge mammalian genetic manipulation techniques, and computational and systems immunology represented by
his primary mentor, Dr. Denise Monack, and a team of leading physician-scientist advisors.

Public health relevance
Project narrative Chronic bacterial infections are major global disease burdens. Understanding the host-pathogen interactions that influence immune responses and bacterial persistence during chronic bacterial infections will lead to novel diagnostic and therapeutic developments. The proposed research will dissect those interactions using a chronic Salmonella infection model.